Neural circuits linking food sensory detection to endocrine and feeding control

Project Summary/Abstract
Feeding is an essential behavior for animals to obtain nutrients for survival, but the influx of nutrients during
and after feeding must be properly managed to avoid disruption of metabolic homeostasis. Neural circuits in
the brain utilize sensory cues associated with food consumption, such as the taste of food and the amount of
ingested food in the digestive tract, to prime endocrine systems for incoming nutrients and regulate feeding
pace and amount. Although progress has been made in recent years to identify neural populations that
regulate endocrine function and feeding behavior, the complete neural circuits that transform food sensory
signals into endocrine regulation and feeding behavioral control are largely obscure. The long-term goal of the
proposed research is to elucidate the complete neural circuits that carry out such sensory-endocrine/feeding
transformations, and obtain a comprehensive circuit-level understanding of endocrine and feeding regulation
and its function in health and disease. To achieve this goal, the fruit fly, Drosophila melanogaster, is used as a
model system. Drosophila has long been a valuable model for neural circuit studies, providing insights into
common principles for chemosensory processing and feeding regulation that are shared with mammals. The
recent completion of an electron microscope connectome of the entire Drosophila brain at synaptic resolution
provides an unprecedented opportunity to delineate complete neural circuits linking food sensory detection to
endocrine and feeding control. Guided by our connectomic analyses, this proposal aims to test the central
hypothesis that a subset of serotonergic neurons in the Drosophila brain integrates both external and internal
food sensory signals to regulate endocrine function and the feeding motor program. Aim 1 will use state-of-the-
art optogenetic and functional imaging approaches to test the hypothesis that serotonergic neurons integrate
food-related gustatory and mechanosensory signals from multiple organs, including external and internal
mouthparts and the digestive tract. Aim 2 will test the hypothesis that serotonergic neurons activate two
parallel output pathways to (a) regulate endocrine function to promote sugar metabolism and digestive
function, and (b) inhibit the feeding motor program to suppress food intake, using a combination of calcium
imaging, optogenetic, metabolic, and behavioral approaches. These studies will reveal a complete neural
circuit from food sensory inputs to endocrine/motor outputs, and provide mechanistic insights into the sensory
integration of external chemosensation and gut interoception, gut-brain-endocrine interactions, and feeding
behavior regulation. The findings from this research will advance our understanding of how neural circuits
regulate feeding behavior and feeding-related endocrine function, providing a foundation for examining how
compromised function of these circuits may contribute to endocrine dysfunction, eating disorders, and obesity.

Public health relevance
Project Narrative Feeding is an essential behavior, and the proper regulation of feeding is crucial for maintaining physical and mental well-being. The proposed research aims to investigate the neural circuit mechanisms that integrate external and internal food sensory signals to regulate feeding behavior and feeding-related endocrine function. Compromised function of these mechanisms may contribute to endocrine dysfunction, eating disorders, and body weight changes including obesity, which collectively afflict a large proportion of the United States population.